Phenotypic variability within isogenic population of lymphocytes

We expanded the project horizon by collaborating with Naomi Taylor (CCR) and Paul François (UMontréal) in order to usher new Chimetic Antigen Receptor (CAR) T cells. CAR T cell therapy has been transformative for blood cancers but remains limited in treating solid tumors due to on-target/off-tumor (OTOT) toxicity. To address this, we engineered T cells to co-express both a chimeric antigen receptor (CAR) and a neoantigen-specific T cell receptor (TCR), enabling "fuzzy logic" control of T cell activation. Unlike conventional Boolean logic systems, our approach allowed for graded responses shaped by the strength of TCR engagement. We discovered that TCR signaling modulated CAR activity in a non-binary, spectrum-like manner: weak TCR signals antagonized CAR activation, while strong signals enhanced it. Using high-throughput robotic assays and a revised adaptive kinetic proofreading (AKPR) model, we mapped the quantitative rules governing this crosstalk. This led us to define and implement an "antagonism-enforced braking system" (AEBS), whereby self-antigen recognition through the TCR dampened CAR function, thus reducing toxicity against healthy tissues. We validated this AEBS system in multiple mouse models of leukemia and solid tumors. Dual TCR/CAR T cells selectively eliminated tumor cells expressing strong neoantigens while sparing healthy cells expressing self-antigens. In humanized models, AEBS T cells preserved anti-tumor efficacy while avoiding damage to normal human lung tissue expressing the same CAR antigen. We further demonstrated that this antagonistic modulation was widespread: many altered peptide ligands (pAPLs) derived from tumor neoantigens acted as CAR antagonists via the TCR. Finally, we engineered AEBS T cells combining a HER2 CAR with TCRs specific for p53 and HHAT neoantigens, showing enhanced tumor specificity and reduced OTOT toxicity across diverse human cancer cell lines. Our work establishes a new therapeutic principle-TCR-controlled fuzzy logic-to enhance the precision of CAR T cell therapies (we filed a provisional patent and hope to start clinical trials soon). This approach opens a pathway for more effective and safer immunotherapies by encoding self-tolerance directly into engineered T cells.